Investigating Histone 3 Dopaminylation in Parkinson's Disease

Summary/Abstract
Parkinson’s Disease (PD) is the second most common neurodegenerative disease affecting nearly one million
people in the United States, and up to 80% of PD patients eventually develop Parkinson’s Disease Dementia
(PDD), many with co-Alzheimer’s Disease pathology. PD is a neurodegenerative disease impacting the
dopaminergic cells in the substantia nigra pars compacta (SNpc), which play a large role in controlling both
movement and cognition. The motor circuit involves the lateral SNpc projections to the striatum, while dementia
phenotypes involve the medial SNpc projections to various cortical and limbic related structures. To date, there
are no significant therapeutics that prevent progression of disease and dementia, highlighting a critical need for
further understanding of PD pathology. Notably, epigenetics has gained prominence, with histone deacetylase
inhibitors showing promise for neurodegenerative diseases, including PD. Recently, H3K4me3, trimethylated
histone 3 at lysine 4, has come to light as a neuroprotector in a drug induced rat model of PD. This proposal
aims to interrogate a novel epigenetic marker, dopaminylation, in PD. Our lab recently established a novel role
for dopamine termed dopaminylation, whereby dopamine acts as an epigenetic marker on Histone 3 glutamine
5 (H3Q5dop), adjacent to the significant H3K4me3 modification. H3Q5dop is covalently attached via the Tissue-
Transglutaminase 2 enzyme to proteins and this process is concentration dependent. Given the loss of dopamine
in PD, there is indeed an observed loss of H3Q5dop in postmortem human PD SNpc tissue and a global loss of
dopaminylation observed in postmortem human PD post-synaptic BA25 cortical tissue. Interestingly, the loss of
H3Q5dop was found in conjunction with and independent of the neighboring H3K4me3 epigenetic modification.
Preliminary findings suggest that H3Q5dop plays an important role in preserving and potentiating H3K4me3
readout, possibly pointing to H3Q5dop’s role in neuroprotection as well. Thus, I hypothesize that H3Q5dop
influences chromatin architecture via enhancing H3K4me3 signal, and its decrease in PD alters cellular
identity, SNpc projections to key motor and cognitive brain regions, and behavior. Firstly, this proposal will
interrogate H3Q5dop in human postmortem SNpc and BA25 prefrontal cortex via the integration of data from
epigenetic regulation, chromatin accessibility, and gene expression. Secondly, in mouse models, this proposal
will assess the loss of H3Q5dop mediated changes to transcriptional identity, SNpc projections, motor function,
and emotion-based learning. This innovative work will offer novel insights into H3Q5dop’s role in the
pathophysiology of PD, establishing a novel therapeutic target. This proposed research will take place at the
Icahn School of Medicine at Mount Sinai, within the Friedman Brain Institute, one of the world’s premier
institutions for translational brain and nervous system sciences. With hopes of becoming a leading physician
neuroscientist, working towards the proposed training goals will equip me with essential skills in molecular,
behavioral, and computational research while advancing my medical training.

Public health relevance
Project Narrative Parkinson’s Disease (PD) arises from a complex interaction between age, genetic composition, and environmental factors that ultimately lead to the loss of cellular identity and death in the dopaminergic cells of the substantia nigra pars compacta (SNpc), leading to altered SNpc signaling to striatal and various cortical and limbic system brain regions. This project will employ a combination of cutting-edge biochemical, molecular, and behavioral techniques to examine the novel role dopamine plays as an epigenetic modification of histone 3 in the SNpc and post-synaptic BA25 prefrontal cortex of PD. The new mechanistic insights on how histone 3 dopaminylation impacts transcriptional identity, cell survival, and motor and cognitive functioning will offer enormous potential on novel targets for therapeutics.